ENVIROMENTAL ASSESSMENT for SLICE® (emamectin benzoate) Type A Medicated Article for Freshwater-Reared Salmonids

PROJECT SUMMARY/ABSTRACT
ENVIRONMENTAL ASSESSMENT FOR SLICE® (emamectin benzoate) Type A Medicated
Article for Freshwater-Reared Salmonids.
Intervet Inc. (d/b/a Merck Animal Health) refers to MUMS designation # 54 granted by
FDA/CVM/OMUMS (I-010418-L-0333-MR; 3/11/2019) under INAD I-010418 for the control
of Salmincola californiensis on freshwater-reared Oncorhynchus mykiss (rainbow trout). Intervet
seeks approval from the U.S. FDA, Center for Veterinary Medicine (CVM) for the use of SLICE®
(emamectin benzoate) Type A Medicated Article for the control of ectoparasites (Salmincola
californiensis) on freshwater-reared salmonids (Oncorhynchus mykiss).
Intervet Inc. has entered into a Cooperative Research and Development Agreement (CRADA)
effective May 01, 2008 with U.S. Fish and Wildlife Service (“FWS”) through the efforts of its
Aquatic Animal Drug Approval Partnership (AADAP) program to support the development of new
aquatic animal related drugs. Under this agreement, the U.S. Fish and Wildlife Service’s Aquatic
Animal Drug Approval Partnership (AADAP) Program could work with CVM and other consultants
(in this case “Exponent”) on behalf of Intervet to complete the Environmental Assessment (EA)
for use of SLICE® in freshwater-reared salmonids. If Intervet is awarded a grant of $250,000.00
from the United States Food and Drug Administration’s Minor Use Minor Species (MUMS) grant
program, the grant money will be used to pay Exponent to complete the EA for use of SLICE® in
freshwater-reared salmonids. Exponent has previous experience working on the EA of the use of
SLICE® in freshwater salmonids as well as in salt water for treatment of Atlantic salmon, and is
familiar with the available data and studies on this product. A detailed cost estimate and schedule
for EA completion is provided in this application.
For the grant, AADAP wrote a protocol for EA completion and submitted it to CVM on February
23, 2021 (amended on May 21, 2021) and obtained acceptance from CVM on June 3, 2021. A
copy of the protocol titled “ENVIRONMENTAL ASSESSMENT for SLICE® (emamectin benzoate)
Type A Medicated Article for Freshwater-Reared Salmonids” and CVM acceptance letter (I-
011370-H-0118-SP; 6/3/2021) are provided in this application.

Public health relevance
Confidential One Mill and Main Place, Suite 150 Maynard, MA 01574 Project Narrative Intervet, Inc. (d/b/a Merck Animal Health) (Intervet) proposes to prepare an Environmental Assessment (EA) to support the use of SLICE® (emamectin benzoate) in freshwater-reared salmonids (trout). The U.S. Fish and Wildlife Service’s Aquatic Animal Drug Approval Partnership (AADAP) Program wrote a protocol for EA completion and submitted it to U.S. FDA, Center for Veterinary Medicine (CVM) on February 23, 2021 (amended on May 21, 2021) and obtained concurrence from CVM on June 3, 2021. The EA will be conducted in accordance with that protocol; Intervet has selected Exponent, Inc. to assist them in the preparation of the EA. 1